FMRI-based Decoupling of Conditioning and Belief Effects on Placebo Analgesia

DESCRIPTION (provided by applicant): This project aims to differentiate between neural mechanisms that underlie placebo analgesia. Currently, many researchers have concluded that placebo analgesia depends primarily on an individual's belief in a treatment, but alternative evidence suggests that other lower level processes may be involved in analgesia that are dissociable from belief. In the proposed study, belief in a placebo treatment will be manipulated using verbal information within subjects, and both experience and belief will be manipulated using conditioning between subjects. The proposed study will separate the effect of verbal information on placebo analgesia from implicit values learned through experience. Subjects are conditioned to believe that a placebo treatment is effective at reducing pain by first receiving a series of high-temperature painful stimulations, and then receiving a second series of low- temperature painful stimuli after the experimenter applies a placebo cream with instructions that it will reduce pain. Half of the subjects will experience a single conditioning session (short conditioning group), and the other half will have four separate sessions on different days (long conditioning group). For all subjects, the placebo effect will be tested in the scanner after the final conditioning session. During testing, subjects will rate the painfulness of medium-temperature painful stimuli with and without the placebo cream. Subjects will then be informed that the treatment they received was a placebo, and will be asked to again rate the painfulness of medium-temperature painful stimuli with and without the placebo cream. Revealing the nature of the treatment allows comparison of fMRI based pain activity at different levels of belief, and allows comparison across groups of subjects depending on how much conditioning they received. FMRI analysis for this project will focus on dissociating the effects of verbal information and experience among pain related brain regions, and whether the relationship between brain activation, pain, and the belief in a treatment is different depending on the amount of training received. We anticipate that pain-related activity in frontal pain areas, including the orbitofrontal and anterior cingulate cortices, will depend on belief in the treatment and that pain-related activity in lower order areas, such as the periaqueductal gray and rostroventromedial medulla, will depend on the amount of conditioning subjects receive. We will use classification techniques to predict which subjects will continue to experience placebo analgesia after the placebo treatment is revealed. We expect to find that activation in the lower order pain regions predicts whether subjects continue to experience placebo analgesia after the reveal. This research will provide a new way of thinking about analgesia and pain relief. If multiple pathways for placebo analgesia are found, it would suggest novel treatments and methods for improving existing pain relief treatments using conditioning to assist the natural pain relief system in the body.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project will examine differences in brain systems governing pain relief. This study will focus on brain regions involved in pain relief, testing whether activity in specific regions predicts the effectiveness of a placebo treatment. The results of this study may suggest various procedures to use placebos to give people pain relief, even if they know the treatment is a placebo. __SpecificAimsTextDelimiter__ The experience of pain, and how to treat it, is a global issue that affects people of all ages and ethnicities. Understanding pain and pain-relieving systems is crucial to developing new methods to treat pain, and placebo analgesia offers a unique opportunity to study these systems in the absence of any chemical treatment. Placebo analgesia can be reliably conditioned by repeatedly pairing a placebo treatment with pain relief (17), but only when subjects are unaware of differences between stimuli (13). Contrasting these two elements has often led researchers to discuss the difference between conditioning and expectancy for pain relief (16) and whether one system could truly govern the placebo analgesic response. Conditioning occupies such a fundamental role in psychological theory that researchers may tend to view it as a unitary process, when in fact it is comprised of a multitude of components. Conditioning is known to affect habit learning (1), value learning (8), declarative memory (7), and may also be involved in generating specific outcome expectations (4). The goal of this research plan is not to address the difference between conditioning and expectancy per se, but to evaluate the separable roles of training and verbal instructions on placebo analgesia, and identify unique neural components of each. The central innovation of this study is the manipulation of expectancy via verbal instruction after during testing of placebo analgesia to determine the unique contributions of verbal information and training on placebo analgesia. A very small number of experiments have used similar procedures (3, 11), but none have done so after the placebo effect has been conditioned, and none have concurrently measured neural activity. Aim 1: Disentangle the contributions of experience-based learning from verbally mediated expectancy to placebo analgesia As learning influences both conscious expectations and habit- and value-learning systems thought to operate independently of expectations, disentangling the contributions of each to placebo analgesia (and conditioned responses more generally) has been a long-standing goal in the field. To address this challenge, we will employ two novel manipulations: A manipulation of conditioning duration will influence both expectation and habit learning, and a manipulation of verbal instructions will influence only expectancy. A "long- conditioning" group of participants will receive 4 days of conditioning, and a second, "short-conditioning" group will receive only 1 day. After conditioning, subjects in both groups will undergo fMRI scanning, during which they will experience medium-intensity painful stimuli both with and without the placebo treatment. After this initial assessment of placebo analgesia, we will verbally instruct participants that the treatment was actually a placebo. In preliminary tests, we have found that this "revealing" is effective in reversing placebo-induced expectations for pain relief. Any remaining analgesia is thus attributable to changes in value-learning systems that operate independent of expectation. In preliminary tests (See Preliminary Data), the long-conditioning group continued to experience pain relief after we revealed the true nature of the treatment, whereas subjects in the short-conditioning group did not. Analgesia in the long-conditioning group persists even though their reported expectancy for pain relief drops to the same level as the short-conditioning group. That is, the long- conditioning group experiences pain relief even when they know the treatment to be ineffective. We expect to observe similar behavioral results in the proposed fMRI study. Additionally, we anticipate disentangling activation in brain regions that primarily use verbal information from those who use experience driven value- learning or both types of information equally. We anticipate activity in frontal pain-associated brain regions (e.g., orbitofrontal cortex, anterior cingulate cortex) to rely more on verbal instructions than simple experience. We anticipate that pain-related activation midbrain and hindbrain areas (e.g., periaqueductal gray, rostroventromedial medulla) will depend on the amount of training: subjects in the short conditioning group will have a similar activation in these areas compared to frontal areas, whereas subjects in the long conditioning group will have dissociated activity between the lower and higher brain regions. This would mean that previous value learning can influence brain activation and need not depend on current verbal knowledge. Aim 2: Classify subjects using machine learning techniques to predict treatment effectiveness Examining individual differences in neural activation that are predictive of whether placebo analgesia is effective or not will provide insight into which brain areas are necessary for placebo analgesia. Identifying areas crucial in determining whether placebo analgesia is effective and whether placebo analgesia continues to be effective despite knowledge to the contrary would be a useful first step in understanding which regions govern the analgesic response. We will use cutting edge classification techniques to identify subjects who are most likely to experience pain relief after the reveal given their brain activity prior to the reveal. This method can help us identify why some subjects respond differently to pain treatments compared to others, and suggest types of subjects who may be more amenable to placebo-based pain relief. We intend to experiment with several types of classifiers, including LASSO-PCR and support vector regression. We anticipate that changes in the frontal cortex will be more important for placebo analgesia in the short conditioning group, whereas changes in the midbrain and hindbrain will be more important for subjects in the long conditioning group.